Novel Approaches for Improving Vascular Function in Veterans with HFpEF

PROJECT SUMMARY: Heart failure with preserved ejection fraction (HFpEF) accounts for greater than 50% of
the 6 million HF cases nationwide, and the prevalence relative to heart failure with reduced ejection fraction
(HFrEF) continues to rise at a rate of 1% per year, presenting an imminent need for further research addressing
the pathophysiology of this pervasive disease. The clinical presentation of HFpEF is defined by dyspnea upon
exertion and severe exercise intolerance, symptoms that are likely due, at least in part, to disease-related
changes in the peripheral circulation. While the mechanisms responsible for vascular dysfunction in HFpEF have
not been established, chronic inflammation and associated production of reactive oxygen species (ROS),
stemming from HFpEF-associated comorbidities and inactivity, appear to play a crucial role. The peripheral
vasculature of this patient group represents an area that is particularly vulnerable to the harmful effects of ROS,
which interact with, and reduce bioavailability of, nitric oxide (NO). The proposed work thus seeks to examine
the mechanisms linking inflammation, vascular health, and exercise tolerance in Veterans with HFpEF, and
identifying which aspects of this cascade could be targeted to improve physical capacity and vascular function
in this patient group. Using a randomized, double-blind, crossover design, a series of experiments are proposed
that will combine novel methodology with targeted pharmacologic interventions to selectively determine the
importance of NO substrate, enzymatic cofactor bioavailability, and inflammation/ROS to disease-related
changes in NO signalling in HFpEF. Specific Aim 1 will test the hypothesis that chronic enteral L-Citrulline
administration (100mg/kg) will increase NO substrate, leading to an increase in NO bioavailability and a
subsequent improvement in vascular function. Specific Aim 2 will explore whether administration of
tetrahydrobiopterin (BH4), an essential cofactor for endothelial NO synthase, can improve enzymatic coupling
and therefore restore vascular function in patients with HFpEF. Specific Aim 3 will evaluate the potential
pleiotropic properties of atorvastatin, a HMG CoA reductase inhibitor, to reduce inflammation and oxidative
stress, leading to improvement in physical capacity and vascular function. Each Specific Aim will combine in vivo
and ex vivo assessments to comprehensively determine the impact of the proposed interventions on the cascade
of inflammation, oxidative stress and exercise intolerance in this patient group. Upon completion, it is anticipated
that the proposed work focused on developing a better understanding of the mechanisms that contribute to
impaired peripheral vascular function in HFpEF, and pinpointing novel strategies to alleviate vascular dysfunction
and promote physical cpacity, will translate directly into an improved ability to perform activities of daily living,
which is likely to lead to improved quality of life and a better prognosis in this Veteran patient group.

Public health relevance
Veterans have a two-fold greater risk of developing heart failure (HF) than non-Veterans. In fact, HF is one of the top causes of hospitalization across the VA healthcare system, and is associated with markedly high annual medical costs. Heart failure with preserved ejection fraction (HFpEF) accounts for greater than 50% of all heart failure (HF) cases nationwide, and the prevalence of this form of HF relative to heart failure with reduced ejection fraction (HFrEF) is growing by approximately 10% per decade. The proposed project seeks to evaluate the mechanisms responsible for disease-related vascular dysfunction and exercise intolerance in Veterans with HFpEF, which will be accomplished through selective pharmacologic targeting of distinct pathways known to regulate vascular inflammation and nitric oxide (NO) signaling. Findings from the proposed work hold the promise of identifying novel therapeutic approaches for enhanced vascular health and exercise tolerance in Veterans with HFpEF, which may lead to an improved quality of life and better prognosis in this patient group.